Developing a robust native extracellular matrix to improve islet function with attenuated immunogenicity for transplantation

Project Summary/Abstract
Compared to daily multiple insulin injections, pancreatic islet transplantation for type 1 diabetes
(loss of β-cells) or the latter stages of type 2 diabetes (β-cells fail to produce sufficient insulin)
provides a near physiologic regulation of normal blood glucose levels and significantly improves
quality of life by minimizing severe hypoglycemia and diabetic complications. However, a
shortage of donors, loss of allograft function over time, and the need for lifelong
immunosuppression must be resolved before this approach can be widely adopted. The overall
goal of this proposal is to improve islet transplantation using a native extracellular matrix (ECM)-
based culture system, which mimics the pancreatic microenvironment, to obtain large quantities
of high-quality islets with attenuated immunogenicity. Previously, we reported that culture of rat
pancreatic islets on native ECM, produced by bone marrow stromal cells, promoted growth of islet
vascular endothelial cells (VECs), production of islet-bm associated proteins, improvement of β-
cell function, and attenuation of islet immunogenicity (Appendix 1). Recently, we developed an
ECM synthesized by human amniotic fluid (AF)-derived pluripotent stem cells. Proteomic analysis
suggested that the protein composition of AF-ECM and pancreatic ECM were similar and this was
validated in our preliminary studies. Moreover, human islets maintained on AF-ECM showed
significantly improved insulin secretion in response to glucose stimulation. Here, we propose to
explore AF-ECM, a surrogate pancreatic-like ECM (pI-ECM), for potential use in maintaining
human islets. We will prepare pl-ECM employing Good Manufacturing Practices (GMP) and
hypothesize that maintenance of islets on pl-ECM, prepared using GMP compliant conditions,
will facilitate the recovery of large numbers of high-quality human islets with decreased
immunogenicity. To test this hypothesis, we will manufacture pl-ECM with reagents and facilities
that are GMP compliant and then compare its architecture, mechanical properties, and protein
composition with our current research use only (RUO) version (Aim 1). We will also compare the
viability, function and immunogenicity of human islets maintained on GMP-compliant versus RUO-
pl-ECM (Aims 2&3). If the proposed work is successful, it will provide the necessary preliminary
data and rationale for moving forward with a small-scale clinical trial and commercialize a new,
GMP-grade version of our matrix product for use in the manufacture of cell products for clinical
applications.

Public health relevance
Project Narrative The proposed work aims to improve islet transplantation using a GMP-compliant, cell-derived extracellular matrix for maintenance of human islets in vitro. Although diabetes is a major public health priority, no curative treatments exist and the most promising treatment is hampered by technical obstacles addressed in this proposal. This work will result in a new approach that facilitates the isolation of islets, improves islet viability, and reduces their immunogenicity, resulting in large numbers of high-quality islets with low risk of allograft immune rejection.